Phenotyping Core

The Overarching Aim of the Yale MPMOD Phenotyping Core is to provide extramural investigators access to
the unique metabolic phenotyping services provided by the Yale MPMOD at a fair and reasonable price, and
empower them to characterize the impact of their genetically manipulated mouse models of diabetes and obesity
on key metabolic parameters and whole body and tissue specific intracellular metabolic fluxes using state-of-
the-art stable and radio-labeled isotope methodology. The Specific Aims of the Yale MPMOD Phenotyping
Core are: 1) To provide the scientific community access to standardized, high quality, unique metabolic
phenotyping services currently available at the Yale MPMOD at a fair and reasonable cost, 2) To continue to
develop novel stable isotope GC-MS, LC-MS/MS and NMR methods to metabolically phenotype whole body and
intracellular metabolism in awake mice, and 3) To participate and collaborate with the National Consortium of
MPMODs and the MPMOD Coordinating Unit to maintain a national database of metabolic phenotyping data in
mouse models of obesity and diabetes. It is anticipated that the results generated by the Yale MPMOD will lead
to a better understanding of the pathophysiology of diabetes and obesity and their related metabolic
complications and lead to new therapies. Ultimately, the insights generated from in vivo metabolic phenotyping
in mouse models will facilitate the development of precision medicine approaches targeting metabolic
pathophysiology and its downstream complications.